YAP and TAZ regulate alveolar epithelial cell regeneration during lung repair

Project Summary: Pulmonary fibrosis (PF) is a chronic relentlessly progressive interstitial lung disease
resulting in progressive loss of respiratory function leading to death of approximately 50,000 patients in the
U.S. each year. Failure of normal epithelial repair processes is believed to play a central role in the
development and progression of pulmonary fibrosis, leading to the loss of normal alveolar type 1 (AT1) and
alveolar type 2 (AT2) and accumulation of alveolar epithelial cells that abnormally co-express genes
associated with both AT1, AT2 and proximal airway epithelial cells. In order to understand how abnormal
alveolar repair contributes to PF disease mechanisms, we must first determine the critical cellular and
molecular mechanisms that facilitate normal alveolar repair and regeneration. Our prior studies and preliminary
data indicate that the Hippo-Yap/Taz signaling pathway is an important regulator of alveolar development and
promotes both AT2 proliferation and early AT1 specification during alveolar repair, but persistent and
inappropriate activation of Yap/Taz signaling may prevent normal AT2/AT1 differentiation and underlie the
dysfunctional epithelial repair seen in PF lungs. During adaptive repair of experimental fibrotic injury Yap is
dynamically expressed in AT2 cells peaking at 7 days post-injury, while Taz is highest at 14 days post-injury in
AT2 cells and readily expressed in most AT1 cells during homeostasis and repair suggesting distinct cell type-
specific roles for Yap and Taz. Others have found that deletion of Taz in AT2 cells prevents AT1 differentiation
and deletion of Yap/Taz in AT1 cells leads to a loss of AT1 cell identity. This leads to our over-arching
hypothesis that dynamic, cell-type-specific, regulation of Yap and Taz activity is essential to guide adaptive
alveolar regeneration. To test this overarching hypothesis will assess the concept that Yap and Taz have
distinct and cell-type specific interaction partners that mediate transcriptional and epigenetic activity that guide
normal lung repair. These concepts will be tested in 2 aims; 1.) To determine the mechanisms by which Yap
regulates AT2 cell proliferation and transitional cell differentiation during alveolar repair, and 2.) To define the
role of active Taz signaling in the differentiation, maturation, and maintenance of AT1 cells. To test these Aims
we will use combinations of in-vivo genetic mouse models, in-vitro organoid models, and ex-vivo precision-cut-
lung-slices to define the role of Yap and Taz during normal and pathologic repair. Successful completion of
these aims will provide vital therapeutic strategies to guide adaptive repair and promote the delay or resolution
of pulmonary fibrosis.

Public health relevance
Project Narrative Failure of normal lung repair is believed to drive the pathogenesis of pulmonary fibrosis. This project investigates the distinct critical cell-type specific roles of the transcription co-factors Yes-associated-protein (Yap) and transcriptional coactivator with PDZ-binding motif (Taz) in alveolar repair and determine if targeting mediators of Yap and Taz transcriptional activity can enhance lung repair to prevent or reverse pulmonary fibrosis.